DBSR- M SANI POTS#10-004415-CONTINUED ACQUISITION OF NEW MEDICARE DATA AS THEY B

The purpose of this contract is to provide continuation of research data capacities through a data archive of HRS data linked with Medicare records. Acumen will continue development and maintenance of data resources for approved users of HRS and PSID datasets linked to CMS records. The availability of these data products will insure uniformity of research file extracts and linkages across multiple users, permitting more accurate replication of findings.